Time-of-flight positron emission tomography using Cerenkov luminescence in bismuth germanate

SUMMARY
Positron emission tomography (PET) is widely used as a diagnostic molecular imaging technique and clearly
has had a significant impact on human healthcare. There have been significant improvements in PET technology
by employing time-of-flight (TOF) capability that measures the difference in arrival time of the two 511 keV
gamma annihilation rays. This TOF information spatially constrains the origin of the event, leading to improved
image quality due to the increased signal-to-noise ratio (SNR) and effective sensitivity in the PET scan.
The scintillator bismuth germanate (BGO), however, has several better properties for PET applications than
L(Y)SO, such as higher stopping power and higher photo-electric fraction. BGO also has no background activity
and can be produced at lower cost than L(Y)SO. However, a major drawback of BGO is the poor coincidence
timing resolution originating from the moderate light yield and slow decay time of scintillation photon production.
Therefore, BGO has not been considered for use in current generation TOF PET scanners.
Theoretically, when a 511keV gamma ray interacts in a scintillator, a small number of optical Cerenkov photons
are produced promptly by energetic electrons released by photoelectric or Compton interactions. The Cerenkov
photons are produced within an extremely short time frame and earlier than scintillation photons, Thus the
Cerenkov photons should provide better timing information for PET. Interestingly, BGO has properties that lead
to it producing more Cerenkov photons than other scintillators.
Recently, we showed, for the first time, the influence of prompt Cerenkov photons on the timing properties of
BGO using latest generation silicon photomultipliers (SiPMs) developed by our partner FBK. Thus, our proposed
concept for BGO is that Cerenkov photons are used to obtain prompt timing information while scintillation photons
provide essential energy information for PET. The major goals of this proposal are i) to improve coincidence
timing resolution of BGO by detecting more Cerenkov photons for TOF PET applications, ii) to develop signal
reducing methods and read-out electronics for signals generated by both Cerenkov and scintillation photons,
and iii) to finally develop and evaluate the first practical BGO-based TOF PET detector modules, which have 5
× 5 cm2 cross-sectional area and a coincidence timing resolution of ≤300 ps FWHM. If successful, this proposal
forms the basis for developing novel BGO-based TOF PET scanners with higher sensitivity and lower cost than
current PET scanners.

Public health relevance
NARRATIVE Positron emission tomography (PET) is a highly specific and sensitive imaging technique that visualizes molecular interactions, having a significant impact on biomedical research and translational medicine. This proposal reinvents bismuth germanate (BGO) scintillator as an exciting scintillator that offers exceptional promise for time-of-flight (TOF) PET using its newly discovered “fast timing resolution”. Combining high sensitivity from TOF capability and no background radioactivity would be highly enabling for very low dose applications. The ability to perform TOF PET with BGO make it worthy of consideration for PET scanners designed for brain, breast, and total body imaging as well.